Advancing evolutionary genetics through deep learning

Project Summary/Abstract
Background: A major challenge in evolutionary genomics is to characterize the forces shaping patterns of
genetic variation. For instance, disentangling the effects of natural selection on genetic diversity from those of
demographic changes is notoriously challenging. This question has important implications for our
understanding of key evolutionary processes: how do species successfully adapt to new selective pressures,
and can we determine which genes were responsible for these adaptations? Researchers typically address
these and similar problems using statistical summaries of genome sequence variation that provide insights into
the evolutionary forces at play. However, because such approaches typically rely on a univariate summary of
the data, valuable information present in the original dataset is lost. A more fruitful strategy would be to use
multidimensional representations of genomic data or even the totality of the input (e.g. a matrix representation
of a sequence alignment). Modern deep learning methods represent an enticing route toward using high-
dimensional representations of sequence data to make accurate evolutionary inferences. As the size of
genomic datasets continue to expand at an ever-growing rate, deep learning methods will need to capable of
leveraging compressed representations of genomic data such as tree sequences: the sequence of evolutionary
trees that changes as one moves along a recombining chromosome.
Proposal: The Schrider Lab develops and applies powerful machine learning methods for evolutionary
inference. We have developed numerous deep learning tools—including several produced under the highly
productive R35 that this application seeks to renew—that leverage high-dimensional representations of
genomic data to make more accurate evolutionary inference than was previously possible. However, we are
only scratching the surface of what deep learning can accomplish in our field. We will therefore develop
modern deep learning tools like graphical neural networks and large language models (LLMs, which
have revolutionized natural language processing) to solve pressing problems in evolutionary genetics.
This work will include the development of efficient tools to make accurate inferences from tree sequence
representations of large genomic data sets. Moreover, we will incorporate recent and ongoing advances in the
interpretability and robustness of deep learning methods into all of our proposed tools. We will use these
methods to answer key evolutionary questions such as the impact of cross-species introgression in
Drosophila, and the manner in which important mosquito vectors adapt to anthropogenic selective
pressures such as insecticides. More broadly, the success of the novel approaches described in this
proposal has the potential to transform the methodological landscape of evolutionary genomic data analysis.

Public health relevance
Project Narrative The work proposed here seeks to develop and apply powerful deep learning software tools for evolutionary genetic inference in mosquito vectors and other species. Such efforts have important health implications—for example, these tools will be used to identify genes involved in adaptations such as resistance to insecticides and other control efforts.